Integration of Drug Release and Permeability with Systems Data Relevant to PBPK Model of Nose-to-Brain Axis and Verification Using Clinical Data

Project Summary
Intranasal (IN) drug delivery is an attractive route as it avoids the hepatic first-pass effect and
has a rapid-onset of action due to direct access to central nervous system (CNS). It has been
suggested as a route to achieve effective drug concentration for treatment of neurological
disorders where drug distribution to the CNS following delivery by other routes may be
challenging due to the presence of blood-brain-barrier (BBB) and/or efflux transporters that
reduce drug CNS exposure. Office of Generic Drugs (OGD) has prioritised access to generic
drugs to ensure safe and effective use in patients. The importance of generic drugs has also
been recognised by the FDA through the Generic Drug User Fee Amendments (GDUFA).
Mechanistic tools such as physiologically-based pharmacokinetic (PBPK) models will further
ensure development of quality, safe and effective generic drugs for delivery by IN route.
Currently, there is no PBPK model in the literature that adequately accounts for important
components such as direct nose-to-brain pathway, the role of transporters in the CNS drug
disposition, the role of complex absorption process and the interplay between all these
dynamic processes. In this project PBPK models for drugs delivered by IN route will be
developed, linking the nose-to-brain pathway to the disposition of drug within the CNS and the
rest of the body. This approach is based on in vitro-in vivo extrapolation (IVIVE) principles and
builds on our current project on development of IVIVE-PBPK models for CNS drug disposition
to link cerebrospinal fluid to localized brain concentration for compounds with mild-to-
moderate efflux liabilities. In our proposal we will focus on three drugs: zolmitriptan, naloxone
and oxycodone. Literature in vitro and clinical data will be used for initial model development;
however, gaps will be filled with experimental data generated within this project. Proteomics
data from olfactory region of human tissue will be generated and implemented in the model to
account for the role of transporters in drug uptake. A prospective dedicated clinical trial
following intravenous and IN delivery of three selected drugs will be used as an independent
dataset for model validation and qualification. These data are critical for PBPK-driven
deconvolution which is necessary to account for entry rate of the drugs following intranasal
delivery, which will also be useful to explore complex interplay between permeability and
transporter kinetics. All our methods and codes will be published for open access by PBPK
users and commercial platform developers to create an immediate path for practical
application by pharmaceutical scientists.

Public health relevance
Project Narrative The project will develop physiologically-based pharmacokinetic (PBPK) models for integration of drug release and permeability data following intranasal delivery of selected compounds, focusing on nose-to brain pathway to account for CNS disposition and the role of blood-brain barrier in this dynamic process. The models will initially be developed using existing literature in vitro and clinical data; any gaps will be filled with dedicated experimental work, including proteomics from olfactory region of human tissue to account for the role of transporter in drug uptake in this region and model validation and qualification will be supported by a dedicated clinical trial following intravenous and intranasal drug delivery. These new clinical data will provide a unique opportunity to carry out an appropriate PBPK-driven deconvolution that is necessary to account for entry rate of the drugs following intranasal delivery into different parts of the body, resulting in mechanistically sound models that integrate extensive knowledge on drug properties and physiological system.